Social Genomic Mechanisms Linking Structural Racism, Perceived Discrimination, and Breast Cancer Survival

PROJECT SUMMARY
Women living in historically redlined neighborhoods impacted by structural racism and discrimination (SRD) have
shorter breast cancer (BCa) recurrence-free survival (RFS) compared to women living in non-historically redlined
neighborhoods. This disparity persists after controlling for individual, behavior, lifestyle, environmental, tumor, and
National Comprehensive Cancer Network guideline-concordant treatment characteristics, suggesting unaccounted
mechanisms by which SRD impact BCa RFS. Our preliminary data indicate that SRD, through neural influences
on BCa biology, may shorten BCa RFS. Specifically, we leveraged the novel genomic-epidemiologic infrastructure
of our Miami Breast Cancer Disparities study, a prospective cohort study with clinically and survey-annotated blood
and tissue samples, to discover that both objective SRD [defined using the Index of Concentration at the Extremes
(ICE)] and subjective perceived discrimination [PD, defined using the using the Expanded Everyday Discrimination
Scale Survey (EEDS)] are independent predictors of 1) higher levels of myeloid lineage immune cell activation in
blood (a pattern known as the Conserved Transcriptional Response to Adversity; CTRA) and 2) a more aggressive
BCa molecular biology profile (up-regulation of proinflammatory transcription factors (TF) NF-kB and AP-1), after
controlling for individual (e.g., age, race/ethnicity, behavior, lifestyle, comorbidities), environmental (e.g., air
pollution), tumor (e.g., stage, subtype), and treatment (e.g., neoadjuvant chemotherapy) factors. In addition, this
aggressive BCa molecular biology profile correlated with shorter RFS. We also discovered that both SRD and PD
are associated with up-regulation of TF CREB (a marker of SNS activity), implicating the SNS as a potential
mediator of SRD and shorter RFS through pro-inflammatory NF-kB and AP-1 regulation. Combined, our preliminary
data provide strong evidence for our central hypothesis that SRD and PD are associated with shorter RFS, in part,
through biologic mechanisms mediated by SNS regulation (CREB) of circulating myeloid lineage immune cells
(CTRA) resulting in an aggressive tumor biology molecular profile. To test our central hypothesis, we propose the
following aims in the largest social genomics BCa study to date, consisting of 750 diverse (∼18% non-Hispanic
White, 24% non-Hispanic Black, and 58% Hispanic) BCa patients enrolled in our MBCD study: Aim 1) Define the
contributions of objective SRD and subjective PD on BCa RFS. Aim 2) Validate the biologic mechanisms mediating
the effects of SRD on RFS. Aim 3) Evaluate the spatial effects of clinical and biologic correlates of shorter RFS.
Combined, these findings, to our knowledge, will represent the single largest social genomics and geospatial BCa
research effort to study BCa RFS disparities with an innovative focus on 1) isolating the distinct biologic
mechanisms associated with SRD (ICE) and PD (EEDS) and RFS, and 2) geospatial identification of at-risk
neighborhoods defined as having more SRD, aggressive biology, and shorter RFS to inform future policy and
targeted behavioral or therapeutic to deduce SNS activity to adversity and thus based on prior randomized control
trials, reverse aggressive tumor biology, ultimately improving BCa RFS for high-risk marginalized populations.

Public health relevance
PROJECT NARRATIVE This research study utilizes advanced bioinformatics and high-resolution spatial transcriptomics to identify social genomic mechanisms linking structural racism (SRD), perceived discrimination (PD), and aggressive breast cancer (BCa) blood and tumor biology as one explanation for why women living in historically redlined neighborhoods have worse BCa recurrence-free survival (RFS) outcomes, even after controlling for individual- level, tumor, and receipt of treatment factors. We will also utilize multiscale geographically weighted regression to identify neighborhoods associated with higher and lower risk-factors for shorter RFS, such as SRD, PD, aggressive biology, which will help us understand what low-risk regions are doing well, and subsequently what interventions can help promote longer RFS in high-risk regions.